AI-Campus Workshops: Revolutionizing Healthcare with AI and Machine Learning

The healthcare sector is undergoing a transformation driven by artificial intelligence and
machine learning (AI/ML) technologies, which offer potential for enhancing research,
optimizing patient outcomes, and increasing healthcare systems' efficiency. However,
many researchers face limited access to resources and opportunities in this field. We
propose a multi-faceted approach, including online competitions and annual workshops
catering to a wide range of participants. We have a strong track record of engaging with
broad participation through AI-Campus and national competition organization
experiences. We have organized events such as the iDASH genomic privacy workshop
and encouraged students to participate in the Dream challenge. Our proposed series of
events, "AI-Campus Workshops: Revolutionizing Healthcare with AI and Machine
Learning," will build upon this track record of success. Aim 1 focuses on creating annual
competitions for healthcare outcome improvements, designing datasets that represent
real-world problems, and providing opportunities to broad participants. Aim 2 involves
organizing annual workshops on the latest AI/ML advances in healthcare, inviting
speakers, and offering experience with the latest tools and technologies. Aim 3 centers on
engaging broad participates, to ensure broad representation in our AI/ML healthcare
initiatives. Through these aims, we will empower participants with essential skills,
knowledge, and connections needed to excel in the healthcare AI/ML landscape. Our
vision is to foster a community of researchers and practitioners committed to advancing
AI/ML in healthcare. By facilitating broad participation, education, and collaboration, we
aim to make a significant impact on AI/ML for healthcare and nurture a community that
propels progress and innovation in healthcare to benefit everyone.

Public health relevance
This project proposes AI-Campus workshops to revolutionize healthcare with AI and machine learning. It uses a multi-faceted approach that encompasses a series of events, including online competitions and workshops. It helps providing more opportunities for participants to engage with AI in healthcare.